The impact of biobehavioral factors and aspirin on ovarian cancer biology

ABSTRACT | FULL RESEARCH PROJECT 2
Growing evidence indicates that the biological response to chronic stress and subsequent distress can
promote the progression of epithelial ovarian cancer via prolonged activation of the sympathetic nervous
system and sustained norepinephrine release. Downstream consequences of norepinephrine exposure
include increased prostaglandin-related inflammation and an immunosuppressive landscape. Conversely,
increasing evidence supports the role of aspirin use in ovarian cancer prevention and survival. Yet, key
questions remain about the underlying biological mechanism of action of chronic stress/distress and aspirin
use (considering low and standard doses separately) and their interrelationship with ovarian cancer biology.
Specifically, we propose to evaluate the hypothesis that distress enhances ovarian cancer progression by
promoting inflammatory and immune processes and that aspirin abrogates these effects. Our innovative study
uses unique population-based and experimental resources. Aim 1 will use data from four long-term
prospective cohorts in diverse populations, a population-based case-control study, a hospital case series that
collected self-reported measures of chronic stress and distress (e.g., depression), and ovarian tumor tissue.
Aim 1 will measure gene expression in bulk high grade serous tumor samples (to capture the full tumor
microenvironment) using whole exome RNASeq. We hypothesize that distress is associated with the up-
regulation of inflammation-related and immune suppression gene expression pathways that is normalized
among aspirin users. We will also assess if the association of distress with ovarian cancer risk is attenuated
among aspirin users. Notably, we are leveraging racially and ethnically diverse studies that have highly
characterized ovarian cancer cases, allowing assessment of differences in association by race (Black,
White) and ethnicity (Hispanic, non-Hispanic), as well as the examination of associations between distress-
related gene expression profiles and clinical outcomes. Using an orthogonal and interactive approach, Aim 2
will use experimental ovarian cancer mouse models to characterize the progressive effect over time of daily
restraint stress on tumor inflammation and immunity as well as ovarian tumor growth, using RNASeq and
stress hormones measured via ELISA assays. We also will examine if aspirin (recapitulating equivalents of
low and standard dose aspirin in humans) counteracts the effects of chronic stress on tumor progression and
inflammatory and immune gene expression networks. This project will leverage the scientific services of
several cores, including the Puerto Rico BioBank (PRBB) and the Quantitative Science Core (QSC), with
substantial interaction with the Outreach Core, the Planning and Evaluation Core, and working with trainees in
the Research Education Core. This innovative application will inform future work to develop novel immuno-
preventive strategies, pharmacotherapies, and psychosocial interventions to prevent and treat invasive
ovarian cancer in women who experience chronic stress and distress.